Novel frameworks for explaining unequal access to the health benefits of social ties: a longitudinal analysis in wild chimpanzees

PROJECT SUMMARY
Social integration and social support have profound and long-lasting effects on health and mortality. With such
advantages, it is surprising that individuals vary so much in their ability to access the health benefits of social
ties. In order to design more effective intervention and prevention strategies involving social support, it is vital
to understand the factors that affect individual engagement with social networks, as well as which features of
social relationships contribute most reliably to health outcomes. Research of this kind is quite difficult with
human subjects given that long and complex social experiences are often distilled into broad subjective and
retrospective measures of social support.
Non-human primates have emerged as tractable and appropriate model systems for investigating interactions
between social processes and health. Primate social bonds yield similar health or survival benefits to those in
humans, yet social behaviors can be directly observed and objectively quantified. Chimpanzees are particularly
valuable comparative models because they are long-lived and socially-complex, share a close genetic
relationship with humans, and exhibit important similarities in social aging trajectories. The Kibale Chimpanzee
Project has collected a dense, longitudinal sample comprising >25 years of systematic, daily observations of
wild chimpanzee social behavior paired with routine monitoring for urinary biomarkers of stress and
physiological health. The currently proposed work capitalizes on the extraordinary capacity of this dataset to
elucidate long-term interactions between stress response systems, social relationship maintenance, and aging.
The overarching goal of this research is to elucidate the factors that affect unequal access to the health
benefits of social ties. Our innovative approach centers on the perspective that the development of beneficial
social support networks entails costly investments and the risk of stressful, health-compromising experiences.
We hypothesize that both early development and aging shape individual sensitivity to relationship stress, which
affects how individuals engage in their social environments. Aim 1 will evaluate how body size and trait
glucocorticoid function, factors influenced by development, predict investment in and quality of social
relationships. Aim 2 will evaluate how relationship quality attributes, such as the stability and equitability of
bonds and the balance of positive and negative interactions, moderate the influence of social bonds on health
and mortality. For Aim 3, we will integrate the results of Aims 1 and 2 into a comprehensive framework by
addressing whether individual developmental traits interact with social relationship quality or act independently
to shape health, and how these influences are modified by changes in sociality during aging. The planning
phase of the research will involve necessary data preparation and development and validation of novel
analytical tools for assessing trait glucocorticoid variation and the multidimensional properties of social bonds.

Public health relevance
PROJECT NARRATIVE Social support exerts profound impacts on health across the life course in humans and other social primates, and is thus a prime target for healthy aging interventions. However, the ability to design effective and long- lasting intervention strategies is limited because there are still few frameworks to explain why some individuals fail to access these health benefits. In this project using wild chimpanzees as an evolutionarily-relevant social aging model, we examine the potential for individual developmental traits and relationship quality attributes to moderate the health benefits of social ties.